Basolateral amygdala support of odor valence learning

PROJECT SUMMARY
Odors are capable of potently influencing emotional and behavioral responses. The ability to detect odors and
assign them hedonic value, or valence, is essential to navigating a world filled with rewards and dangers.
Olfactory sensory loss is correlated with changes in emotional responses, reductions in memory, lack of appetite,
and overall apathy. Despite strong evidence that odors acquire appetitive and aversive valence, the neural
circuitry underlying odor valence learning is unknown. The basolateral amygdala (BLA) acts as a hub for the
integration of multisensory information, including olfactory input, with aversive and appetitive outcomes. While
there is ample compelling evidence that the BLA encodes for positive (reward) odor valence encoding, whether
the same holds true for negative (aversive) odor valence learning is not clear. This is especially true given that
studies to date used mildly aversive quinine, which could obscure the firing dynamics associated with more highly
aversive outcomes. Dopamine is a potent neurotransmitter that influences cellular plasticity and learning in the
BLA, but its influence on odor-valence behavioral learning is unclear. In the proposed F31 NRSA, I will test the
hypothesis that through learning, BLA neurons represent the full spectrum of odor valence, both positive and
negative, and that the display of learned odor valence behaviors is regulated by dopamine. I will use a
combination of electrophysiological and computational methods, optogenetic stimulation, and site-specific
pharmacology as mice engage in a go/no-go behavioral task wherein odors are either rewarded or punished.
The results from Aim 1 will demonstrate that BLA neurons encode the full spectrum of learned odor valence
while the results from Aim 2 will determine the influence of dopamine within the BLA on odor valence learning
behavior. Overall, these findings will enhance our understanding of how the brain processes and assigns
emotional significance to odors. Furthermore, the results from this project will expand our understanding and
appreciation for the role of dopamine in olfactory processing, and has implications for human disorders
characterized by disturbed affective regulation.

Public health relevance
PROJECT NARRATIVE Odors are powerful drivers of emotional responses, and aberrant assignment of emotions to odors underlies a variety of human neuropsychiatric conditions. The results of this project will enhance our understanding of how odors acquire emotional significance, and will expand our knowledge of the brain regions and neurotransmitter systems involved. This proposal therefore supports the NIH and NIDCD’s mission to understand how odors are processed in the brain to support perception and ultimately behavior.